Data Science Core

DATA SCIENCE CORE SUMMARY
The AK INBRE 5 Data Science Core overall goal is to provide resources, services, and training in data science for investigators and students. The Data Science Core will execute these aims in alignment with the NIH Strategic Plan for Data Science. The Data Science Core will enhance Alaska-based resources, promote new expertise, and support access to resources outside of Alaska where gaps in infrastructure or expertise exist. These activities will maximize NIH and AK institutional investments and provide training essential for data science in biomedical research. Execution will promote best practices in data management, the utilization of biomedical data repositories, and enhanced opportunities for cloud computing. The Data Science Core will collaborate with other INBRE Data Science Cores to provide richer opportunities for training and research. In summary, the AK INBRE 5 Data Science Core will provide a comprehensive set of resources and services to support data science research in Alaska. The Data Science Core will focus on providing access to data infrastructure, tools, and expertise, as well as training and career development opportunities. The DSC will work to collaborate with other INBRE Data Science Cores to provide the best possible support for data science research in Alaska.